BLR&D Research Career Scientist Award Application

The mission of my Neuroimmunology Research Program is to develop a deep biological understanding of
autoimmune, demyelinating and neurodegenerative processes that affect the central nervous system (CNS)
and to identify and test novel disease-relevant therapies that can be brought to market to treat and/or cure
these conditions. Veterans are currently developing intractable chronic neurological diseases such as multiple
sclerosis (MS) and stroke, service related injuries including traumatic brain injury (TBI) and post-traumatic
stress disorder (PTSD), and substance abuse of alcohol and methamphetamine. Studies carried out by our
laboratory are highly relevant to these devastating conditions due to our development of a novel therapy that
targets a common underlying mechanism, the MIF/CD74 axis that promotes chronic inflammation in the CNS
and other tissues. MIF (macrophage migration inhibitory factor) and its homolog D-DT (D-dopachrome
tautomerase) are highly inflammatory cytokines that trigger release of other inflammatory factors upon binding
and signaling through their common receptor, CD74, a chaperone for loading self and foreign peptides into
MHC class II molecules on antigen presenting cells (APC). The result of MIF/CD74 signaling is peptide-specific
Teffector cell activation and recruitment of inflammatory cells from blood into the CNS. Our initial unique
therapeutic construct, called RTL1000 is comprised of linked DRα1 and DRβ1 domains of HLA-DR2 (an MS
risk factor) covalently linked to myelin oligodendrocyte glycoprotein (MOG) 35-55. This construct has
conformational similarity to naturally occurring MHC class II/peptide T cell receptor ligands, but induces T cell
tolerance when present in soluble form without cell-bound co-stimulatory molecules on APC. This construct
has immunoregulatory and neuroprotective properties in a mouse model of MS (experimental autoimmune
encephalomyelitis, EAE) and was shown to be safe and well tolerated in a Phase 1 study in MS. RTL1000 will
soon be tested in a multi-dose MS clinical trial. The major breakthrough in understanding the potent effects of
RTL1000 occurred in 2013 with the discovery of CD74 as the cellular receptor for RTL1000. This led to the
unifying discovery that RTL1000 could competitively inhibit binding of both MIF and D-DT to CD74 and thus
short-circuit MIF/CD74 signaling that is present in essentially all of the VA targeted CNS conditions. Molecular
modeling of MIF binding revealed two discrete CD74 regions that bound to homologous sequences on MIF and
D-DT and to the DRα1 moiety of RTL1000, thus explaining RTL1000’s competitive inhibition. However,
RTL1000 can only be used in ~60% of MS subjects that express HLA-DR2. We thus designed a new
construct, DRα1-MOG-35-55 that retained the activities of RTL1000 and could modulate CD74 and
competitively block MIF binding, resulting in a significant treatment effect and neuroprotection in chronic EAE.
Of interest, RTL1000 and DRα1-MOG-35-55 were more effective in treating chronic EAE in male mice due to
an antagonist effect of estrogen receptor (ESR1) in females. An evaluation of MIF, D-DT and CD74 in a ~600
subject clinical study (to be published in PNAS) revealed that male subjects with a high expression genotype
for MIF (and D-DT) had an increased risk of developing progressive MS. This unique observation raises the
possibility that early treatment of males with RTL1000 or DRα1-MOG-35-55 might prevent conversion to
progressive MS and potentially would be effective for treating MS subjects with progressive disease. FDA IND
approval of DRα1-MOG-35-55 preclinical studies would allow treatment of all MS subjects regardless of the
HLA type due to its non-polymorphic, universal expression that would be tolerated by all humans and thus
could be injected without tissue typing. Of broader importance, we have demonstrated that RTL1000 and
DRα1-MOG-35-55 constructs can also treat other CNS conditions in experimental mouse models including
experimental stroke, vascular dementia, traumatic brain injury and methamphetamine induced cognitive
disability, thus providing a novel potential therapy for Veterans that develop these devastating conditions.

Public health relevance
Studies carried out by my laboratory are highly relevant to the treatment of acute and chronic degenerative conditions of the central nervous system (CNS) that often afflict Veterans. We have developed of a novel therapeutic approach that targets a common underlying mechanism, the MIF/CD74 axis that promotes inflammation in the CNS and other tissues. Our unique therapeutic constructs, called RTL1000 and its second generation derivative, DRα1-MOG-35-55 competitively inhibit binding of both MIF and its homolog D-DT to a common receptor (CD74) and thus short-circuit MIF/CD74 signaling that drives essentially all of the VA targeted CNS conditions. Our work has demonstrated that DRα1-MOG-35-55, which can be administered without the need for tissue typing, could potentially be used to treat Veterans with multiple sclerosis as well as other devastating CNS afflictions including stroke, vascular dementia, traumatic brain injury and methamphetamine induced cognitive disability, thus addressing a critical unmet need for the VA.